Pancancer discovery and exploration of shared splicing neoantigens

PROJECT SUMMARY
Cellular and immunotherapies are increasingly emerging as front-line treatments in clinical oncology. However,
current immune checkpoint blockade therapies improve outcome in only a subset of patients for a few cancers.
While immunotherapy is typically reserved for cancer patients with a high mutational burden, neoantigens
produced from post-transcriptional regulation provide an untapped reservoir of common immunogenic targets
for new targeted cancer therapies. To identify and exploit alternative mRNAs for the design of shared therapies,
our team of computational and cancer biologists developed an innovative workflow to define and experimentally
validate diverse forms of splicing neoantigens (Science Translational Medicine 2024). Our computational
workflow, called Splicing Neoantigen Finder (SNAF), employs innovative artificial intelligence approaches to
accurately predict shared immunogenic splicing neoantigens that can serve as the basis for broadly used
immunotherapies. In addition to MHC presented neoantigens, SNAF defines novel expressed cell surface full-
length neo-peptides from long-read sequencing data. Our computational and experimental studies demonstrate
the feasibility of highly shared splicing neoantigens as targets for therapy in multiple solid and hematological
malignancies, find shared neoantigens that span diverse malignancies, nominate new mechanisms underlying
their regulation (splicing failure) and suggest a subset of antigens specifically derive from the tumor
microenvironment. To capitalize on these new findings, we propose to create a comprehensive splicing
neoantigen atlas of 30 adult and pediatric malignancies that span both known and novel disease subtypes. This
work will establish clear roles for splicing neoantigen burden and the tumor microenvironment across cancers,
define key molecular and extrinsic regulators (e.g., viral infection), and nominate recurrent liabilities for future
vaccine and immunotherapy development. These analyses are expected to reveal thousands of highly shared
splicing neoantigens, derived from distinct regulatory mechanisms, that are both specific to and recurrent across
malignancies. To interactively explore and interrogate this pancancer splicing neoantigen atlas, we will develop
an advanced web portal called NeoXplorer. NeoXplorer will build upon our recently developed and intuitive
pancancer splicing analysis web infrastructure, to facilitate comparative cancer and healthy tissue analyses of
splicing neoantigens, clinical and genetic covariates, orthogonal genomics and long-read sequencing evidence,
advanced visualizations of protein structure and neoantigen immunogenicity and putative splicing regulators.
The proposed atlas and tools will establish a crucial knowledgebase and interfaces to define highly shared and
recurrent therapeutic targets that will have long-lasting impact on the field of cancer biology.

Public health relevance
NARRATIVE New cellular and immunotherapeutic strategies are desperately needed to eliminate malignant clones and halt progression of cancers with poor treatment outcomes. We propose to build a comprehensive pancancer atlas of splicing neoantigens to nominate, rank, and compare novel targets for the creation of new cancer therapies. The proposed work utilizes breakthrough methods in the detection and interactive exploration of splicing neoantigens.